Enabling Technology to Screen and Quantify Sialylated Structures for Activity Against Viral Enzymes and Receptors

Sialylated glycans are involved in complex regulation and signaling and play a critical role in disease.
In the virus life cycle, receptor binding and sialic acid cleavage to facilitate release can compete and
are therefore delicately balanced. While monovalent binding with a single sialylated ligand is weak (KD
~mM), hemagglutinin forms a trimer, which enables multivalent binding. Multivalent binding involving
more than 1 ligand leads to strong binding (KD ~nM). This switch between multivalent and monovalent
binding allows the hemagglutinin to bind to the host with high affinity that is easily reversed following
internalization, replication, by cleavage of only some of the sialylated ligands. Neuraminidase inhibitors
for influenza (Tamiflu, Relenza, and Rapivab) block the neuraminidase cleavage in some infections.
The development of therapeutic strategies to block hemagglutinin binding with small molecule sialylated
inhibitors has been limited. Several analytical barriers to the analysis of sialic acids and sialylated
compounds have challenged research in this area. The long term objective of this project is to bridge
this gap with enabling technology through two key innovations. A new screening approach for enzymes
and receptors is introduced through the use of thermally reversible nanogels. With this new strategy,
the sialic acid structures that interact with enzymes or receptors are identified through capillary
electrophoresis. This work is based on rapid in-line exoglycosidase reactions facilitated with patterned
nanogels. A new capillary electrophoresis-mass spectrometry interface based on acousto-mechanical
energy is introduced to enable coupling both techniques without concern for voltage or flow rate. Aim
1 creates a new functional screening tool for enzyme inhibition and reduces both the amount of enzyme
and the time to evaluate a neuraminidase preparation. The biocompatibility, automation, and low
reagent and sample requirements are harnessed in Aim 2 to establish a quantitative screening tool to
select and evaluate enzyme inhibition of sialylated structures that interact strongly with the receptor
binding domain of the hemagglutinin protein. The full power of label-free structural identification of
capillary electrophoresis interfaced to mass spectrometry outlined in Aim 3 leverages the
unprecedented gains in signal with electrically assisted vibrational sharp edge ionization, overcoming
barriers of current analytical technologies for the analysis of sialylated glycans. The proposed activities
are significant because the low cost, speed, and automation of the separation-based microscale assays
yield previously unattainable information about sialylation fundamental to mitigating viral infections.
These new tools address challenges associated with chemical analyses of sialylated structures to
leverage the role of sialylation in viral infections; thereby, providing researchers the means to combat
viral diseases and advance human health.

Public health relevance
This proposal addresses the compelling need for new tools to study the relationship between human health and the role of sialylation in viral infections. Enabling technology that overcomes current limitations in the field will be used to rapidly characterize and then quantify sialylated glycans on the microscale in order to evaluate the inhibition and binding induced by these molecules.